Probing paradoxical alcohol effects on approach (versus avoidance) of trauma processing in drinkers with PTSD

Project Summary / Abstract
Trauma and posttraumatic stress disorder (PTSD) commonly present among individuals seeking
treatment for alcohol use, and trauma sequelae can considerably challenge alcohol treatment approaches.
Following trauma, humans often turn to social connections to process their experiences. Yet, trauma and
posttraumatic symptoms also can engender mistrust of others, interpersonal vulnerability, fear of rejection, and
social avoidance that disrupt adaptive, protective social support. Unmet drives for social processing might lead
individuals to seek out alcohol to facilitate interpersonal connection. Social motivations are the most common
reasons for drinking broadly, and alcohol has been shown to increase reported social bonding, interpersonal
disclosure, and perceived closeness. Despite this, current theoretical models attempting to explain PTSD-
related drinking overwhelmingly suggest that drinkers turn to alcohol to avoid processing trauma-related affect.
Such theoretical emphasis on negative reinforcement has shaped current treatment efforts for PTSD-related
problem drinking, which often focus on processing and/or confronting trauma experiences to presumably
reduce avoidance-based drinking. However, the research teams’ preliminary findings from focus groups of
frequent drinking adults with provisional PTSD suggest that many drinkers also report drinking to approach
processing trauma memories, thoughts, and emotions, particularly in social drinking contexts. Such perceived
effects of alcohol on social trauma processing may play a key role in maintaining PTSD-related drinking yet, to
date, have not been tested. The proposed study aims to characterize the extent to which drinkers with PTSD
anticipate beneficial trauma processing effects before social drinking events (i.e., expected trauma processing;
Aim 1) and whether drinkers experience social drinking events as having facilitated trauma processing (i.e.,
experienced trauma processing; Aim 2). Efforts also will characterize drinkers’ reflections of trauma processing
in these specific drinking events, including aspects of the social context and relevance of trauma processing to
future posttraumatic symptoms (Aim 3). Frequent drinking adults with PTSD (n = 100) will complete
momentary surveys before and after drinking events in a 21-day ecological momentary assessment (EMA)
design. Drinkers who report expected or experienced trauma processing (a subset, n = 20) will provide in-
depth, idiographic information through a follow-up qualitative interview on the perceptual, sociocontextual, and
successive factors at play in such drinking events. Findings will begin to characterize the extent to which
perceived trauma processing effects encourage individuals to seek out social drinking in the aftermath of
trauma and/or reinforce PTSD-related drinking over time, thus suggesting the need for larger investigations.
Future research can explore psychosocial/physiological mechanisms underlying any such effects, and clinical
research could work to modify extant interventions to encourage trauma processing in the absence of alcohol.

Public health relevance
Project Narrative Theoretical frameworks overwhelmingly attribute posttraumatic problem drinking to use of alcohol to avoid processing undesired trauma memories and emotions, but preliminary qualitative data suggest that at least some adults may turn to social drinking to approach (versus avoid) trauma processing. The proposed mixed methods study explores both expected and experienced trauma processing in naturalistic social drinking events within a sample of frequent drinkers with posttraumatic stress disorder (PTSD). Findings may suggest the need to modify clinical approaches to incorporate trauma processing reasons for drinking and/or provide supplemental alcohol supports to enable trauma processing without unexpectedly increasing drinking.